Biostatistics Core

BIOSTATISTICS CORE: PROJECT SUMMARY
The Biostatistics Core Resource will provide comprehensive biostatistics and bioinformatics consultation and
collaboration to all Research Projects in the proposed Johns Hopkins Ovarian Cancer SPORE. Core members
will work with project investigators across a wide spectrum of activities, encompassing data acquisition (including
study design, feasibility of objectives, availability of public-access genomic information, and data storage),
statistical quality control (including artifact detection and preprocessing of data from genomic technologies), data
analysis (including visualization, biostatistical modeling, and assistance with manuscript writing), and
development of innovative customized biostatistical methodologies and tools if required by specific projects. The
proposed Ovarian Cancer SPORE Biostatistics Core is housed in the Division of Oncology Biostatistics and
Bioinformatics of the Department of Oncology, an active and committed group of biostatistics and bioinformatics
faculty members, with access to state-of-the art equipment and a broad range of expertise. This Core resource
builds on expertise gained by Core members who actively participate in other SPOREs at Johns Hopkins. Core
members have a strong commitment to this SPORE, stemming from: a) a history of collaboration with the
investigators on this other research projects in ovarian cancer, b) an active and independently funded agenda of
synergistic projects in cancer genetics and genomics, and c) a demonstrated interest and understanding of both
the biological and analytical questions and challenges. All proposed Projects are anticipated to make use of this
Resource.

Public health relevance
BIOSTATISTICS CORE: PROJECT NARRATIVE The Biostatistics Core will serve as a centralized resource to all Ovarian Cancer SPORE investigators and promote synergy across different projects and resources. It will enhance the abilities of projects to address key translational questions that will lead to a reduction in the morbidity and mortality of ovarian cancer.